Next generation spatial genomics tools for the human brain

SUMMARY
Spatial genomics in human brain tissues has the ability to visualize gene expression programs in
complex cell interactions that are involved in many neurological disorders. However, current
spatial technology is often limited by the high autofluorescence in human brain samples and the
poor RNA quality. At Spatial Genomics, we have commercialized the Gene Positioning System
(GenePS) platform that is based on the sequential fluorescence in situ hybridization (seqFISH)
technology (Eng et al, 2019) that allows 10,000 genes to be imaged directly in tissue samples.
The major goal of this project is to develop next generation reagents to scale up the multiplexity
of assays available on the GenePS instrument. We will develop new assays that can be
performed robustly across human brain tissues by the GenePS platform.

Public health relevance
NARRATIVE Robust tools to perform spatial transcriptomics in human brains are needed to help understand basic molecular mechanisms of neurological disease. Elucidating the interactions between distinct cell population of neurons and non-neurons in the brain are key for understanding the immune and micro-environment interactions underlying dysfunction. We will develop novel reagents for spatial imaging technologies to map cell types and discover signaling pathway genes across cells in the human brain that are inexpensive and easy to perform. The success of this project will enable robust analysis of human brain slices for spatial transcriptomics across a wide- range of neuroscience research.